Non-invasive Imaging of Pathological Fibrin Deposition and its Effect on Progressive Neurodegeneration in the Human Brain: an in vivo longitudinal study

A growing body of evidence indicates that fibrinogen and the pathways that control the
formation and degradation of fibrin could represent early triggers that contribute to the
initiation of neuroinflammation and the promotion of neurodegeneration in a variety of
neurological disorders including multiple sclerosis (MS), a neuroinflammatory and
neurodegenerative disorder of the CNS and the most common cause of neurological
disability (after trauma) in young adults in Western countries. In MS, accumulating
evidence indicates that fibrin deposition is prominent and diffuse throughout the course
of the disease, both in the white matter (WM) and in the cortex, where it is thought to
trigger demyelination, axonal and neuronal loss.
Using a novel fibrin-specific molecular imaging approach based on 64Cu-FBP8 brain
positron emission tomography (PET), developed at Massachusetts General Hospital for
detecting fibrin deposition in the human brain, we have obtained preliminary in vivo data
that demonstrate abnormal fibrin deposition in the brain and cortex of progressive MS
cases. The significance of such findings is still unknown. Our overall hypothesis is that in
vivo quantification of fibrin deposition by 64Cu-FBP8 uptake could be used to track the
evolution of areas of cortical and WM pathology related to MS disease progression by
investigating whether, and to which extent, the amount of fibrin deposition relates or can
even predict different components of tissue damage including demyelination and/or
neurodegeneration, as suggested by postmortem examinations. To test our hypothesis,
we propose an innovative, longitudinal, imaging approach that will combine 64Cu-FBP8
imaging on an integrated 3 Tesla (T) magnetic resonance-PET system with the Rapid
Estimation of Myelin for Diagnostic Imaging (REMyDI) a novel MRI-based myelin
quantification technique and with 7T MRI to assess cortical lesion load and chronic
active WM lesions, harboring a peripheral rim of iron-laden microglia, visible as a
paramagnetic rim on susceptibility-sensitive MRI, which are associated with,
remyelination failure. 7T imaging has been crucial for in vivo visualization of cortical
demyelinating lesions in MS and following its evolution. Our study will help establishing
the existence of an in vivo link between fibrin deposition and detrimental brain structural
pathology in progressive MS and for assessing 64Cu-FBP8 molecular imaging as a non-
invasive imaging biomarker for fibrin related pathology in the CNS.

Public health relevance
Strong experimental evidence indicates that fibrinogen and its degradation products represent main triggers of neuroinflammation in a variety of neurological conditions. Despite this compelling evidence, diagnostic and clinical use of fibrin(ogen) deposition in the human brain beyond rudimentary immunohistochemical detection on post-mortem samples has not been achieved yet. We propose a multimodal imaging study that will combine 64Cu-FBP8, a novel positron emission tomography probe developed at Massachusetts General Hospital, to image and quantify in vivo pathological deposition of fibrin in the human brain, with a specific focus on progressive multiple sclerosis (MS), with quantitative MR protocols at 3 and 7 Tesla MRI, to assess, longitudinally, the relation between brain fibrin deposition and neurodegeneration.